Genome-wide mutational integration for ultra-sensitive plasma tumor burden monitoring in immunotherapy

PROJECT SUMMARY
A major gap in cancer diagnostics is that state-of-the-art imaging and other existing methods fail to reliably detect
low levels of cancer known as minimal residual disease (MRD), which remain following surgical resection of
early-stage tumors or treatment of advanced disease. Left untreated, MRD can proliferate and result in lethal
cancer recurrence. Hence, there is a critical need to sensitively detect MRD in order to optimize adjuvant
therapies or precision immunotherapy. Liquid biopsy offers the ability to noninvasively monitor MRD by detecting
circulating tumor DNA (ctDNA) originating from cancer cells. Nonetheless, detection of ctDNA is challenging due
to extremely low levels of ctDNA in low-burden disease. The prevailing paradigm argues for deep targeted
sequencing of informative loci. However, we have shown that this approach faces fundamental barriers to
sensitivity due to the low amount of available DNA in typical plasma samples, which imposes a physical ceiling
on depth of sequencing. To overcome this challenge, our interdisciplinary team of geneticists, computer
scientists, and oncologists developed MRDetect, an orthogonal approach for ctDNA detection based on
genome-wide mutation aggregation of single-nucleotide variants (SNVs) and copy number variants (CNVs) using
whole-genome sequencing (WGS) of plasma. MRDetect enables ultra-sensitive MRD detection down to one part
in a hundred thousand, and we have demonstrated its ability to detect MRD shortly after surgery or treatment in
colorectal cancer, melanoma and non small-cell lung cancer (NSCLC). Our objective in this project is to develop
crucial advances that will foster broad-based adoption of this technology across cancer settings. First, we
propose to incorporate advanced machine learning (ML) framework known as ‘deep learning’ (DL) into the
MRDetect platform to enable SNV identification in plasma WGS in low tumor burden settings (Aim 1). This will
yield MRDetect-DL, which we anticipate will significantly improve cancer detection at low tumor levels through
a >100-fold improvement in signal to noise enrichment compared to MRDetect. MRDetect-DL performance will
be tested in high-risk post-operative melanoma to define the need for adjuvant therapy, as well as in advanced
melanoma treated with immunotherapy for precision immunotherapy applications. Critically, MRDetect-DL will
obviate MRDetect’s need for a matched tumor sample, ensuring broad adoption across different clinical settings.
Second, we posit that in addition to SNV-based advances, MRDetect’s sensitivity can be increased by enhanced
detection of CNVs, as these are broadly observed in solid tumors. We propose to develop MRDetect-CNV, an
ML-denoising technique to ultra-sensitively detect small CNVs using plasma WGS (Aim 2). We will test
MRDetect-CNV on NSCLC plasma samples from patients undergoing neoadjuvant immunotherapy to define its
ability to predict treatment response. Impact: Pairing MRDetect-DL with MRDetect-CNV will significantly improve
low burden cancer detection in adjuvant, neoadjuvant, and systemic immunotherapy, enabling broad clinical
application in oncology.

Public health relevance
PROJECT NARRATIVE The ability to detect low levels of cancer is crucial for cancer diagnosis and treatment; however, even state-of- the-art techniques such as imaging and ‘liquid biopsy’ through deep sequencing fail to detect cancer when the tumor burden is extremely low, as can occur after treatment or surgery when small numbers of cancer cells remain. To address the challenges of detecting such low levels of cancer we propose to make non-incremental advances in our promising recently developed technology – MRDetect – which uses a sample of the patient's blood to find low levels of tumor by employing powerful computational tools of artificial intelligence to dramatically boost cancer detection. We expect that these advances will also foster broad adoption of this new technology across cancer, empowering precision cancer treatment.